The Role of the Group B Streptococcus Type VII Secretion System in Polymicrobial Environments

PROJECT SUMMARY
Group B Streptococcus (Streptococcus agalactiae, GBS) is a Gram-positive, β-hemolytic bacterium and a
leading etiologic agent of neonatal bacterial meningitis and major opportunistic pathogen in neonatal, pregnant,
elderly, and diabetic populations. During pregnancy, GBS asymptomatically colonizes the vaginal tract of 30%
of healthy women but can result in adverse pregnancy outcomes and severe neonatal disease. GBS is also
increasingly isolated from adult diabetic wound infections. Both the vaginal tract and diabetic wound are complex
polymicrobial environments. However, despite the public health burden of GBS, little is known about how GBS
competes with these diverse populations to establish a niche and persist in either host environment. The Type
VII Secretion System (T7SS) in Firmicutes secretes diverse toxic effectors that play an important role in
interbacterial competition and virulence. Prior work from our laboratory has shown that the GBS T7SS
contributes to cytotoxicity and virulence during meningitis as well as persistence in the murine vaginal tract during
colonization. However, the specific mechanisms by which the GBS T7SS contributes to colonization as well as
its role in other host environments remain unknown. My preliminary data indicate that the GBS T7SS inhibits
growth of the important vaginal pathobiont and diabetic wound pathogen Enterococcus faecalis in vitro and in
vivo in the murine vaginal tract. Additionally, I have found that a T7SS-associated LXG protein is a putative
intracellular toxin that inhibits growth of E. coli and is important for persistence in the murine vaginal tract and
diabetic wounds. Based on this, I hypothesize that the GBS T7SS mediates competition with neighboring
bacteria in the vaginal tract and diabetic wound and may be mediated by a secreted LXG toxin with nuclease
activity. This proposal seeks to evaluate the interaction of T7SS with the native vaginal microbiota in GBS
colonization of the vaginal tract, interrogate the role of a T7SS-associated toxin in interbacterial competition, and
elucidate the importance of GBS T7SS to diabetic wound infection. These goals will be addressed in vitro and
in in vivo murine models of vaginal colonization and diabetic wound infection in the following specific aims:
Aim 1: Characterize the importance of T7SS to GBS interbacterial competition and vaginal colonization.
Aim 2: Evaluate function of a GBS LXG toxin and its contribution to T7SS interbacterial competition.
Aim 3: Investigate the role of GBS T7SS in diabetic wound persistence.

Public health relevance
PROJECT NARRATIVE Group B Streptococcus (GBS) is an opportunistic pathogen that frequently colonizes the female reproductive tract and is a leading cause of neonatal meningitis as well as diabetic wound infections in non-pregnant adults. However, the specific mechanisms by which GBS outcompetes diverse polymicrobial populations and establishes a successful niche in these host environments are poorly understood. This proposal seeks to investigate how the Type VII Secretion System and its associated toxin contribute to GBS competition with relevant commensals and pathobionts and subsequent establishment in the female reproductive tract and diabetic wounds.